Advancing Neurosymbolic AI for Smart and Trustworthy Healthcare

Project Summary
Artificial intelligence (AI) is poised to transform healthcare, particularly in clinical decision support for treatment
selection in a range of diseases. However, AI is underutilized in clinical care, in part due to two unique
challenges: 1) noisy and complex health data, such as multi-modal electronic health record (EHR) data, and 2)
demand for a high degree of trustworthiness in treatment selection use cases. Explainability is a core principle
of trustworthy AI, but may be lacking in current state of the art (SOTA) AI models for healthcare, particularly for
analysis of multi-modal EHR data. Most notably, current approaches to explainable AI in healthcare based on
post-hoc explanations of black-box models are unlikely to offer clinically meaningful and actionable
explanations to clinicians and end-users, thereby decreasing trust and buy-in. Furthermore, treatment effect
estimation and selection based on inaccurate explanations may cause patient harm. As such, there is an
urgent need for inherently explainable AI/ML models in healthcare that also enjoy the robustness and
expressivity of modern deep learning models. Our preliminary work suggests that incorporation of explanations
based on existing clinician domain knowledge would be a key facilitator for trusting AI models that predict
treatment benefit. However, to the best of our knowledge, no existing SOTA AI models effectively incorporate
clinical domain knowledge into explanations. To address these gaps, we propose to develop Med-Scallop, a
novel methodology and associated software tool based upon the emerging paradigm of neurosymbolic AI. This
paradigm can effectively integrate deep neural models with symbolic domain knowledge from human experts
(e.g. physicians), yielding neurosymbolic programs that are more robust, data-efficient, and interpretable than
their neural or symbolic counterparts alone. Our preliminary quantitative and qualitative results suggest that
Med-Scallop can generate clinically meaningful explanations for clinical decision support (CDS) and facilitate
AI-physician collaboration. We propose to assess the performance of our proposed neurosymbolic AI models
using two clinical use cases for guiding optimal individualized treatment selection and management for patients
with non-small cell lung cancer and sepsis, using multi-institutional EHR datasets for training and validation.
Our specific aims are to 1) develop inherently explainable neurosymbolic AI architectures for treatment
selection using temporal EHR data; 2) integrate multi-modal clinical data into a neurosymbolic framework for
faithful and accurate treatment selection; and 3) develop Med-Scallop, an open-access software platform for
neurosymbolic AI for CDS, as well as a comprehensive mixed-methods methodology for assessing clinical
validity and usability of explanations from AI models. Our approach represents a new, transformative approach
to harness the benefits of both deep neural networks and interpretable symbolic models without suffering their
limitations and the power of rich yet complex EHR data.

Public health relevance
Project Narrative A mechanisms designed key component of trustworthy AI for clinical decision support is explainability the representation of t he underlying AI systems' operation and the meaning of AI systems' output in the context of their functions We propose to develop Med-Scallop, an - . explainable neurosymbolic AI model for guiding clinical management and treatment selection using multi-modal electronic health record (EHR) data that can incorporate domain knowledge from healthcare providers to generate clinically meaningful, faithful explanations. We will evaluate and validate Med-Scallop using both quantitative and mixed-methods approaches in clinical use cases in oncology and sepsis, using three large EHR databases collectively representing millions of patients across the United States.